MECHANISMS AND TREATMENT OF CEREBRAL ISCHEMIA

Clinically, stroke is a leading cause of death and disability. Information that elucidates the pathogenesis and leads to effective therapy of this condition would have important socio- economic implications. This study is part of a long-range investigation into the cellular pathophysiology of cerebral ischemia and potentially beneficial treatments for the cerebral insufficiencies of stroke. Cerebral ischemia results in an increase in lactic acid that has been linked to the production of irreversible changes in brain cell structure and function, especially in animals that have ben treated with glucose before the ischemic event. Preliminary studies in this laboratory have shown that pre- or postischemic treatment with dichloroacetate (DCA) significantly reduces the levels of cerebral lactic acid in a stroke model in both fasted and fed rats. If cerebral lactic acid is a major contributor to cellular functional and structural pathophysiology of this condition, treatment with DCA should ameliorate these effects. Therefore, the objectives of this study are: (a) to analyze and correlate elevated lactate and the effects of treatment with DCA on survival, neurological function, distribution of brain metabolites, energy levels, and presence of edema, as well as cell viability, activity, and ultrastructure in a stroke model in the fasted and fed rat; (b) to determine the effects of DCA on pyruvate dehydrogenase (PDH), the enzyme by which DCA is hypothesized to mediate its lactate lowering effect; and, (c) to determine how PDH mediates this effect in a stroke model in the fasted and fed rat. This model combines bilaterial carotid ligation and systemic hypotension to produce partial global ischemia for 10 min that is followed by reperfusion for varying periods of time prior to sacrifice. The following techniques will be used to accomplish the aims of this study: (a) neurological (survival and locomotor testing); (b) physiological (mean arterial blood pressure, electroencephalograph and somatosensory evoked response recordings); (c) biochemical (brain metabolite analysis, energy charge calculation, blood Pa02, PH, and HC03, and serum metabolites); (d) biophysical (tissue specific gravity); and (e) neuropathological (Evans Blue extravasation; enzyme histo- and cytochemistry; and, routine light and electron microscopy using morphometry). The data of this study will contribute to the development of an effective treatment of stroke and a more complete definition of the role of lactic acid in the pathogenesis of irreversible damage caused by in incomplete cerebral ischemia.